Case CCC Youth Engaged in Science, 09/01/2022-08/31/2027

PROJECT SUMMARY/ABSTRACT
The overall objective of this R25 Youth Enjoy Science (YES) Grant Application from the Case Comprehensive Cancer Center, Case Western Reserve University, Cleveland Ohio, aims to support, develop and implement exciting education, research immersion, outreach and curriculum development activities to attract and mentor URM students in middle and high school progressing to college undergraduate and science teachers to enhance diversity of the cancer healthcare and research workforce. This program is a partnership between the Case CCC, supporting all cancer related research efforts at CWRU with the surrounding area schools of the Cleveland Metropolitan School District and East Cleveland Schools, both of which are an economically and academically challenged urban school districts. Cleveland is recognized as being one of the poorest major cities in the U.S. This R25 program for URM students, their teachers and families build, and expands on our successful high school student targeted, Scientific Enrichment and Opportunity Program and our experience with the R25 YES Program. These programs have been developed to engage promising high school students from the CMSD to interact with the SOM faculty, to participate in exciting, longitudinal research experience, to enhance student interest in pursuing careers in biomedical research and healthcare professions, especially as they relate to cancer. The R25 YES Program extends and enhances our efforts to provide a coordinated sequentially integrated approach consisting of 1) Learn to Beat Cancer, a program targeted to engage URM Cleveland area middle school students, their families and teachers to become knowledgeable about cancer prevention and cancer research opportunities; 2) Research to Beat Cancer, a program designed to attract promising URM Cleveland high school and undergraduate students to cancer education and research immersion opportunities at the Case CCC; and 3) Teach to Beat Cancer, a program designed to provide special research and education opportunities for teachers of URM students to enhance their cancer related knowledge and education skills, engage in curriculum development and enhance their enthusiasm and ability to promote careers in cancer research and diversity in the biomedical work force as well as to further engage the community for increased interaction with the Case CCC.

Public health relevance
PROJECT NARRATIVE The R25 YES Program, under the auspices of the Case CCC will develop and implement cancer education, research immersion, community outreach and curriculum development targeted at middle school, high school and undergraduate college students, as well as to their teachers, families and friends to foster better understanding of the cancer process, promote risk reduction strategies, encourage elimination of cancer disparities and stimulate pursuit of careers in cancer research and healthcare delivery.